Online Mindfulness-Based Couple Therapy for Generalized Anxiety Disorder

DESCRIPTION (provided by applicant): Generalized Anxiety Disorder (GAD) is a substantial public health problem (Wittchen et al., 2000). There is growing evidence that the most efficacious treatments for GAD are third-wave behavioral therapies focused on the principles of mindfulness and acceptance (Roemer et al., 2009). At the same time, it seems to be the case that interpersonal variables such as satisfaction with a romantic relationship, partner hostility, and partner accommodation of GAD symptoms negative affect the course and even the response to treatment of GAD (Durham, Allen, & Hackett, 1997; Zinbarg, Lee, & Yoon, 2007). These findings suggest it will be useful to develop a treatment that combines mindfulness of anxiety and worry with an existing couple therapy method that also focuses on increasing mindfulness of interpersonal behavior, Integrative Behavioral Couple Therapy (IBCT). The present study is a treatment development study of such a combined therapy, IBCT-GAD. The primary goal is to establish treatment principles for the conjoint treatment of GAD and conduct a preliminary test of efficacy in altering GAD symptoms, credibility for patients, and proposed mediators (e.g., hostility and relationship satisfaction). In order to make recruitment of an adequate sample of couples who are distressed and also include one partner with GAD more feasible, this test will occur in an online setting. We will build an online version of IBCT-GAD (similar to an existing online IBCT) and recruit forty couples to participate in an open trial.

Public health relevance
Generalized Anxiety Disorder (GAD) is a mental illness characterized by excessive worry that interferes with the person's everyday life (Wittchen et al., 2000); although treatments for GAD exist, they are substantially less effective when the patient has a romantic partner who is critical and hostile or when the romantic relationship is distressed (Durham, Allen, & Hackett, 1997; Zinbarg, Lee, & Yoon, 2007). Therefore, this study will create and test the effectiveness of a couple-based treatment for GAD (presented in an online format) that simultaneously uses the same treatment principles of becoming more aware of and changing your behavior to alter both the GAD symptoms and the relationship problems that may be affecting the GAD. This research has the potential to substantially improve our ability to treat this form of previously treatment-resistant GAD and thus reduce the public health burden created by GAD.